Shared Resource Management

SHARED RESOURCE MANAGEMENT – ABSTRACT
Shared Resources are organized and maintained to meet the scientific needs of the members of Karmanos
Cancer Institute (KCI). KCI operates eight center-managed Shared Resources as follows; Animal Model and
Therapeutics Evaluation Core (AMTEC), Biobanking and Correlative Sciences (BCS) Core, Behavioral
and Field Research Core (BFRC), Biostatistics and Bioinformatics Core (BBC), Epidemiology Research
Core (ERC), Microscopy, Imaging, and Cytometry Resources (MICR) Core, Pharmacology and
Metabolomics Core (PMC), and a Proteomics Core. Together, these Shared Resources provide access to
specialized technologies, services, and expertise that enhance scientific interaction and productivity at the
Cancer Center. Of the 1,775 peer-reviewed articles published by cancer center members during the current
reporting period (12/1/2015 – 11/30/2019), 561 (31.6%) articles utilized the services of at least one KCI Shared
Resource.
KCI Shared Resources are managed within the planning and evaluation structure of the Cancer Center including
senior leadership oversight of the scientific and strategic progress, reporting and business management provided
by Administration, and regular user feedback provided through survey tools and Core Advisory Committees.
Future plans are proposed to address the needs of the membership and the scientific progress of the Cancer
Center. Additionally, a developing Cyclotron-Radiochemistry Core will provide various radiotracers for pre clinical and clinical research conducted by the Cancer Center membership on a fee-for-service basis. CCSG
funding for Cores was augmented by institutional support in excess of $6.0 million directed to ensure success of
Shared Resources.